Developmentally Programmed Remodeling of Apical ECM

Abstract
Apical extracellular matrix (aECM) coats the outward-facing surface of every organ, forming a barrier
between the organism and its environment. Although it has been viewed historically as a static layer,
aECM has been recently revealed to be dynamic across development and highly varied between cell
types. It plays important roles in shaping organ morphogenesis and modulating cell activity. Identifying
the regulatory mechanisms that control aECM composition and structure is therefore critical to
understanding its role in development. Further, because aECM is highly accessible, there is enormous
potential to manipulate it for targeted delivery of therapeutics or in tissue engineering. The major
obstacles to studying aECM remodeling are that changes in aECM are difficult to visualize and need to
be studied in vivo during highly dynamic processes that involve complex cell rearrangements. This
project overcomes these obstacles by using an innovative model of developmentally programmed aECM
remodeling. Preliminary data lead to the hypothesis that aECM structure is a discrete modular feature of
cell identity, analogous to neurotransmitter types in neurons, rather than a continuum of stiffness/density.
The C. elegans cuticle is an aECM that forms barrier between the animal and its environment. In
order to directly access the external environment, the ciliated endings of some sensory neurons protrude
through nanoscale pores in the cuticle, while those of other sensory neurons are embedded in
specialized sheets of cuticle. Both types of cuticle structure are produced by glial cells that wrap the
sensory neuron endings. One of these glial cells offers a remarkable example of developmentally
programmed aECM remodeling: in juveniles of both sexes and in adult hermaphrodites it produces a
cuticle sheet, but in adult males it produces a cuticle pore. This represents a discrete aECM remodeling
event that occurs at a defined developmental stage without any major cell rearrangements. Preliminary
data show that this aECM remodeling event is accompanied by a switch in gene expression in the glial
cell. This includes expression of GRL-18, a novel class of aECM component that forms nanoscale rings
in the cuticle. These observations leads to the hypothesis that a developmentally regulated switch in
gene expression induces remodeling of aECM to form a nanoscale pore.
To test this hypothesis, this project will (Aim 1) use mutant analysis and transcriptional profiling to
define the gene expression switch that accompanies aECM remodeling; (Aim 2) determine how a novel
developmentally regulated protein (GRL-18) contributes to aECM structure; and (Aim 3) test if changes
in expression of GRL-18 and co-regulated genes are sufficient to remodel aECM into a nanoscale pore.

Public health relevance
Project narrative The apical extracellular matrix (aECM) forms the interface between tissues and the outside world, plays critical roles in organ development and function, and offers a highly accessible therapeutic target. This project will identify novel components of aECM and show how they lead to changes in aECM structure during development. It will reveal how aECM remodelling occurs and will suggest approaches to target this key cellular interface in the context of disease.